Development of a robust HIV-1 diagnostic system (HIV-eCaDI) for at-home testing

Human immunodeficiency virus (HIV) is a highly contagious global pathogen that infects millions of individuals
annually. Almost 38 million individuals worldwide are living with HIV, and approximately 62% with HIV are
receiving antiretroviral therapy. Rapid, sensitive, and accurate detection of HIV infection is critical for
controlling transmission and accurately prescribe antiviral treatment to patients. Laboratory-based detection of
HIV genomes, antigens and specific antibodies in patient samples is commonly used detect acute HIV
infection, but tends to be slow and require in-clinic sample collection. Rapid point-of-care diagnostic HIV
assays are commercially available for Pre-Exposure Prophylaxis (PrEP) patients but are relatively insensitive
and cannot detect early phase infections or directly detect viral particles to indicate an acute infection,
increasing the chance of unknowingly transmitting HIV to their partners. Therefore, development of new types
of low-cost at-home HIV diagnostics are urgently needed to improve HIV detection and help clinicians, public
health departments, and individuals limit the spread of HIV.
The goal of this application is to continue development of a novel electrochemical diagnostic system we call
the HIV electrochemical Capillary-Driven Immunoassay (HIV-eCaDI) to selectively detect HIV-1 p24
antigen present in patient blood samples at limits of detection of 10 pg/ml in a simple, rapid, and inexpensive
format that can be easily perform at home by individuals undergoing PrEP. HIV-eCaDI is a fundamentally
different point-of-care system that integrates inexpensive automated unpowered microfluidic sample
preparation with a highly sensitive and accurate electrochemical detection modality to provide robust
diagnostics results that can rapidly provide critical data to physicians and public health departments. The heart
of this system is our eCaDI system, a disposable hybrid paper/plastic-based electrochemical sensor unit we
have developed that is designed to automate sample preparation and analyte detection in patient blood
samples. The disposable eCaDI cartridge is integrated with an inexpensive custom onboard near field
communication potentiostat that is powered and controlled by the user’s mobile phone, providing simple,
robust, and user-friendly HIV monitoring and patient data management. The proposed HIV-eCaDI system
leverages a number of different Colorado State University strengths (infectious diseases, electrochemistry,
microfluidics platform development) with deidentified clinical samples from Columbia University Medical Center
towards development and validation of a single fully integrated and highly adaptable system to rapidly detect
HIV infection early that will save lives and help HIV positive individuals maintain quality of life.

Public health relevance
Project Narrative Simple and sensitive detection of viral load in patient blood samples at home is highly desired for detection of early and rebound HIV infections, especially in individuals undergoing PrEP. The goal of this project is to develop a novel electrochemical diagnostic platform we call HIV-eCaDI (HIV Capillary Driven Immunoassay) that can be used by PrEP patients to detect HIV p24 antigen at ~10 pg/ml concentrations at home in a rapid, sensitive, and user friendly format. HIV-eCaDI will be a valuable diagnostic platform for detecting acute HIV infections and help patients closely monitor their HIV status in the privacy of their own homes.